STSS: SMART IRB ONLINE RELIANCE SYSTEM (ORS) AND JOINDER ENHANCEMENTS SUPPORT SERVICES

Through its Clinical and Translational Science Awards (CTSA) Program, NCATS is developing a single institutional review board (IRB) platform for multisite clinical studies: the NCATS Streamlined, Multisite, Accelerated Resources for Trials (SMART) IRB Platform. The goal is to provide flexible resources that investigators nationwide can use to harmonize and streamline IRB review for their own multisite studies.